Protection of kidney from autoimmunity by modulating co-stimlatory signaling

Project Summary
Kidney inflammation occurs in response to ischemic injury, infections, and activation of autoreactive or
alloreactive lymphocytes and contributes to chronic kidney damage, fibrosis and end-stage kidney diseases.
Adaptive immune responses are tightly controlled in the kidney to prevent excessive inflammation and to
maintain tolerance against self-antigens. However, the fundamental understanding of the mechanisms
supporting immune regulation in the kidney is incomplete. Clinical observations suggest that the co-stimulatory
molecules such as PD-1 and CTLA4 play pivotal roles in regulating immune responses in the kidney, as
observed in acute interstitial nephritis or kidney allograft rejection in patients treated with immune checkpoint
inhibitors. Studies have elucidated the contribution of adaptive immunity in kidney inflammation. However, the
mechanistic study on the roles of antigen-specific T cells in kidney inflammation is far from complete due to the
lack of appropriate animal models to precisely track antigen specificity and this hinders development of specific
targeted therapy in autoimmune kidney diseases. To close this knowledge gap, we developed two new
transgenic mouse models in which the expression of self-antigens can be specifically induced in proximal
tubules or podocytes, the main target anatomical segments in the autoimmune kidney diseases. By combining
these animal models with a tetramer-based antigen-specific T cell tracking technique to detect endogenous T
cells that recognize specific peptide-MHC complexes, we are able to analyze their phenotype and function in
vivo. The overall goal of this project is to dissect the mechanisms of tolerance against kidney-restricted
antigens. Our preliminary data indicated that kidney-specific expression of self-antigens induced tolerance
against these antigens; however, administration of anti-PD-1 and anti-CTLA4 could overcome the tolerance,
manifested as infiltration of antigen-specific T cells into kidney interstitium. We hypothesize that the tolerance
in the kidney is regulated by the co-stimulatory molecules expressed in antigen-specific T cells and their
ligands found in kidney parenchymal cells or antigen presenting cells; and that disruption of the tolerance
would lead to maladaptive inflammation in the kidney. To test this hypothesis, we will investigate T cell
tolerance mechanism at steady state (Aim 1), characterize kidney-infiltrating pathogenic T cells (Aim 2), and
dissect the roles of antigen presenting cells in tolerance and autoimmunity (Aim 3).
These models provide a novel and innovative approach to study antigen-specific adaptive immune response in
autoimmune kidney disease and represent unique preclinical tools, which will lead to identification of novel
therapeutic targets. In addition, after completing this K award, I will establish my own translational research
project in the intersection of immunology and kidney biology. Developing this research project will be an
exceptional opportunity to become proficient in specific basic research methodologies (e.g. transcriptomics)
and in kidney biology research.

Public health relevance
Project Narrative Autoimmune kidney disease is the leading cause of end-stage kidney diseases, which affect more than two million people and put significant health and economic burden not only in the United States but also worldwide. Overall goal of this career development proposal is to identify the mechanisms of immune tolerance in kidney tissue microenvironment, focusing on the signaling pathway that controls immune cell activation. We aim to identify potential therapeutic target molecules by developing a new animal model to study autoimmune kidney diseases, providing the technological and intellectual framework necessary for the applicant to develop an independent research program in this discipline.